Development of a novel TB vaccine safer and more effective than BCG based on a precisely controlled replication-limited Mycobacterium tuberculosis engineered for optimal in vivo growth and clearance

ABSTRACT
Tuberculosis (TB), caused by Mycobacterium tuberculosis (Mtb), is one of the world's leading causes of
death. BCG, the only licensed vaccine against TB, is an attenuated bacterium highly homologous to Mtb, yet
safe in immunocompetent individuals because it has lost several genes that confer virulence. BCG has good
efficacy against TB in children, but poor efficacy against TB in adolescents and adults. Hence, a vaccine much
more potent than BCG is clearly needed. However, any replacement vaccine will almost certainly need to be
based on modified (e.g. recombinant) BCG or attenuated Mtb to preserve the substantial benefits of BCG.
The goal of this project is to develop an attenuated Mtb mutant that is safer and more potent than BCG.
Our novel strategy involves manipulating two key characteristics of live vaccines: (1) their initial period of
growth in the host and (2) their rate of elimination. The inadequate protective efficacy induced by BCG and
non-replicating Mtb mutants can be attributed, at least in part, to their lack of replication in the host. Prolonged
persistence in the host is also a negative factor, resulting in the generation of primarily effector and effector
memory T cells rather than central memory T cells, important for long-term immunity. We hypothesize that
limited replication of an Mtb mutant for a brief period after immunization, mimicking the early stage of a natural
Mtb infection, followed by rapid clearance will induce a potent immune response and yet avoid the negative
inflammatory responses induced by prolonged Mtb infection.
To achieve our goal, we first shall engineer an attenuated Mtb mutant defective in both of its iron acquisi-
tion pathways - siderophore-mediated iron acquisition (SMIA) and heme-iron acquisition (HIA). Such a mutant
will be unable to obtain iron from the host but can be pre-loaded in vitro with the precise amount of iron to allow
optimal replication in the host. Thus, an Mtb ∆SMIA ∆HIA mutant will allow us to address the first important
factor - controlling the extent of replication in the host. While growth of Mtb ∆SMIA ∆HIA in the host will cease
once it exhausts its supply of iron, the organism may persist for a prolonged period. Thus, to address the
second important factor, the rate of clearance from the host, we shall further modify Mtb ∆SMIA ∆HIA, via two
approaches – 1) knocking out persistence genes and 2) conditional silencing of essential genes. While both
should result in improved clearance, conditional silencing likely will result in faster clearance. We shall vaccin-
ate mice with persistence and conditional silencing mutants and perform clearance and protective efficacy
studies to determine the optimal replication and clearance. We expect a replication- and persistence-limited
Mtb mutant with rapid clearance will be much more efficacious than BCG and, in contrast to BCG, safe even in
an immunocompromised host. Once we have optimized the vaccine for protective immunity in mice, we shall
examine its immunogenicity in mice to assess preliminary correlates of protection, assess its safety in immuno-
compromised SCID mice, and examine its safety and efficacy in a second animal model of TB - guinea pigs.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Tuberculosis, one of the world's most important diseases, with 10 million cases and 1.6 million deaths in 2017, is the leading cause of death from a single infectious agent worldwide (and among the top ten causes of all death). BCG, the currently administered vaccine against tuberculosis, is only partially effective. This proposal will apply a combination of novel strategies to develop a vaccine that is safer and much more potent than BCG, comprising a highly attenuated Mycobacterium tuberculosis engineered for precise control of its in vivo growth and clearance so as to maximize its immunoprotective response and simultaneously eliminate its capacity to disseminate in an immunocompromised host.